Estrogen-mediated mechanisms of stress susceptibility

Project Summary
Women are twice as likely as men to suffer from stress-related affective disorders, and as a result, are also at
a greater risk of developing comorbid cardiovascular disease. This proposal investigates the estrogen (E)-
mediated neural mechanisms that we suggest are initiated in the central amygdala (CeA) to promote innate
stress vulnerability to both the emergence of negative valence and exaggerated cardiac sympathetic activation.
The proposed series of studies relies on the use of a witness stress paradigm whereby a male or female
rodent is located in a protected region of a dominant resident's cage and witnesses a social conflict between
the resident and a smaller male intruder. Following stress exposure, females with either intact ovarian
hormones, or ovariectomized with E replacement (OVX+E) exhibit negative valence (decreased sucrose
preference, increased burying) and exaggerated cardiac sympathetic levels (elevated resting blood pressure)
while OVX with vehicle replacement (OVX+V) and intact males are resilient, making this model ideal to study
the role of estrogen on increased stress susceptibility. Aim 1 expands upon preliminary data that support the
hypothesis that ovarian hormones, in particular E, exacerbate stress susceptibility. These studies will identify
sex differences and estrogenic effects on behavioral and sympathetic indices of stress-related pathology. Aim
2 utilizes direct intra-CeA administration of an E receptor (ER) agonist (DPN) or antagonist (PHTPP), to
activate or block, respectively, the ERs in the CeA. We hypothesize that inhibiting the ER in this brain region
will enhance stress resiliency in the innate susceptible (intact-cycling) and induced susceptible (OVX+E)
female groups, while activating the receptor will promote vulnerability in the induced resilient group (OVX). One
known effect of E is its ability to increase the stress-related neuropeptide corticotropin-releasing factor (CRF), a
peptide that is abundant in the CeA and is capable of inducing enhanced behavioral and sympathetic fear
responses. Our data indicate that intact females exhibit increased CRF in the CeA, but only if they have a
history of stress exposure. Therefore, Aim 2 will also identify if these ER treatments affect CRF expression in
the CeA. Finally, Aim 3 will use virus-mediated gene transfer to reduce CRF levels in the CeA to determine
whether the susceptibility-enhancing effects of the E are dependent upon CRF. Moreover, using in vivo
microdialysis, studies in Aim 3 will identify whether increased CRF in the CeA has consequences on the major
stress sensitive target the locus coeruleus (LC). CRF release and neuronal activity will be measured in the LC
during stress/control and will identify if intact females exhibit increased CRF release in the LC and whether this
translates to elevated activity. The ability of shRNA CRF knockdown in the CeA to affect LC activity and CRF
release will also be assessed. Together, these studies will provide evidence of a targeted mechanism
increasing susceptibility to affective disorders and comorbid cardiac dysfunction in females. These studies
propose a novel and “translatable” pathway by which E may regulate innate stress vulnerability in women.

Public health relevance
Project Narrative Women with active circulating ovarian hormones are twice as likely to develop depression than males. This increased susceptibility begins during puberty and ends following menopause, suggesting that ovarian hormones contribute to the increased incidence of major depression in females. The overall goal of this project is to identify how ovarian hormones interact with stress-related neurochemicals within the brain to increase susceptibility to depressive-like behaviors.